INFUSION OF ATRIAL NATRIURETIC FACTOR AND SYMPATHETIC NERVOUS SYSTEM

The present study aims to delineate some of the mechanisms of ANF resistance when infused in patients with end stage heart failure. This will be done by studying the hemodynamic, neuroendocrine, platelet ANF receptor function, renal function and peripheral sympathetic nervous system changes that occur during infusion of ANF in normal volunteers and in patients with severe CHF.